Registry and Surveillance System in Hemoglobinopathies (RuSH)

In collaboration with the CDC, NHLBI will provide funds for the Surveillance component of the project entitled “Registry and Surveillance System for Hemoglobinopathies (RuSH)”. This component is entitled “RuSH-Surveillance.”